Clinical Sciences Core

PROJECT SUMMARY
THIRD COAST CFAR CORE C: CLINICAL SCIENCES CORE (CSC)
In 2017, new HIV infections in Chicago decreased somewhat, and 92% of persons diagnosed with HIV were
linked to care within 12 months of diagnosis. However, major problems remain. Only 36% of persons living with
HIV (PLWH) in 2017 were retained in care, and only 48% achieved viral suppression. In addition, successes of
antiretroviral therapy (ART) have led to a rising population of older PLWH, which has made aging-related
comorbidities a proximate threat to well-suppressed PLWH and ultimately an increasing public health challenge.
Thus, the needs to improve real-world effectiveness of treatments, as well as HIV prevention, continue. The
Clinical Sciences Core (CSC) will intensify its support of research that addresses these problems, building on
infrastructure and linkages that we have created within and between Northwestern University (NU) and the
University of Chicago (UC). An expanding group of community organization partners also increases reach to
service providers, now notably including Howard Brown Health (HBH) that has expanded sites to areas of most
need and has a long commitment to the health of the LGBTQ community in Chicago. Offering CSC expertise
and services across disciplines and institutions is central to our mission and supports the development of new
scientific partnerships. This expertise includes human subjects research on streamlining ART and studying
aging-associated comorbidities and inflammation. Our accomplished and dynamic Clinical Informatics Group
(CIG) will continue advancing researcher access to sophisticated techniques for computation, analyses of
Electronic Health Record (EHR)-derived data, and emerging digital tools for research participants. The CSC also
emphasizes disseminating research findings and best practices, as well as engaging with community-based
clinics and HIV screening programs. The long-term goal of the CSC is to significantly increase the number of
outstanding clinical investigators, and the trans-disciplinary resources available to them, in order to fuel
discoveries that will propel us towards the end of the HIV epidemic. The CSC’s specific aims to reach this goal
are to: 1) support clinical research that interacts with HIV-infected and at-risk participants, and/or obtains and
studies clinical data and specimens from them; 2) catalyze and support new research on non-AIDS
comorbidities, including clinical phenotyping and pathophysiology of inflammation and accelerated aging in HIV;
3) expand research collaborations and linkages among study participants, clinical HIV researchers, HIV care
providers, other implementation partners and trainees. In the next project period, the CSC commits to expanding
the scope and impact of research on non-AIDS comorbidities among PLWH on ART as a major contributor to
TC CFAR’s Overall aim 2. Each of the CSC specific aims contributes to Overall aim 2 on non-AIDS comorbidities,
and the intent is to increase the CSC users’ trans-disciplinary research on aging and comorbidities in HIV.

Public health relevance
A Project Narrative is not required per the RFA.